Randomized Controlled Trial of a Novel Smoking Cessation Application Tailored to Individuals with Serious Mental Illness.

PROJECT SUMMARY/ABSTRACT
Tobacco use remains at alarming high rates amongst individuals with serious mental illness, such as
schizophrenia spectrum, bipolar, and recurring depressive disorders. Smoking tobacco is the number one
preventable cause of death in this population, shortening the lifespan of adults with serious mental illness by
25 years and contributing to $317 billion in healthcare expenditures and indirect loss of earnings and disability
benefits. Novel and effective models to deliver wider-reaching smoking cessation interventions to individuals
with serious mental illness are highly needed and indicated as a priority for NIH. Mobile apps are a promising
method to deliver smoking cessation treatments to people with serious mental illness. Despite numerous apps
available to use for people with serious mental illness, our feasibility research has demonstrated that using
these apps presents daunting challenges for this population. Based on this work, we developed Learn to Quit,
a user-centered smoking cessation app tailored to the needs of individuals with serious mental illness. The
app’s main active ingredient is a novel behavioral treatment that has shown promise as a smoking cessation
intervention -- Acceptance and Commitment Therapy. The app provides education about the use of nicotine
replacement therapy and recommendations from US Clinical Practice Guidelines to ensure alignment with best
clinical practices. In a recent pilot randomized controlled trial (R00 DA037276), comparing Learn to Quit versus
NCI’s QuitGuide, we demonstrated: (1) high recruitment and retention rates, (2) high levels of user
engagement with Learn to Quit, (3) an effective method to conduct a large multi-site randomized controlled
trial, and (4) promising cessation outcomes. While this developmental work provides initial evidence of Learn to
Quit’s usability, feasibility, and preliminary efficacy, a large scale randomized controlled trial is needed to test
its efficacy in a representative sample of patients with serious mental illness. Therefore, the proposed study
will: (1) employ a randomized parallel arm design to compare the efficacy of Learn to Quit vs. NCI’s QuitGuide,
(2) use rigorous methods to evaluate mediators of app engagement and app efficacy, and (3) examine the
cost-effectiveness of Learn to Quit compared to a non-tailored app designed for the general population. The
study addresses a serious problem -- high smoking rates among people with serious mental illness -- and
proposes to test the efficacy of an easily-accessible smoking cessation intervention, using technology with the
potential for high population-level reach.

Public health relevance
PROJECT NARRATIVE Smoking tobacco shortens the lifespan of adults with serious mental illness by 25 years and contributes to $317 billion in healthcare expenditures and indirect loss of earnings and disability benefits. In prior work, we developed a new model to deliver wider-reaching smoking cessation interventions to individuals with serious mental illness. This project proposes to test the efficacy of this new model in a multi-site randomized controlled trial.